Interdisciplinary Training in Auditory Neuroscience

PROJECT SUMMARY/ABSTRACT
There is a national need to advance the understanding of hearing in both healthy patients and those with
various causes of hearing loss.
The objective of the proposed program is to train the next generation of faculty
who could populate colleges of science, engineering, and health sciences, as well as to send graduates into
in order to advance
auditory neuroscience training, this new graduate program will leverage faculty expertise in basic hearing
science and technology development, from three Purdue University colleges (Science, Engineering, and
Health & Human Sciences) and 6 doctoral admissions programs. Two types of investigators are included in the
training program: 10 hearing scientists with focused research programs related to auditory system
neuroscience, and 7 technology innovators who are trained in other disciplines (electrical, computer and
biomedical engineering, and chemistry). Collectively and collaboratively, the program will expand knowledge
about mechanisms at the molecular, cellular and systems levels that underlie auditory information processing.
This fundamental knowledge can then be applied to better understand the changes that lead to pathologies of
the auditory system due to damage, disease, aging, and congenital disorders, as well as understanding how
hearing evolved and influences behavior and natural selection. Technological approaches to these questions
include, but are not limited to, fluorescent sensors to detect purinergic signaling in the intact nervous system,
biological implants for neuromodulation, high-resolution four-dimension calcium imaging deep in the
mammalian brain, optogenetics and robotics (automated patch-clamping) for brain circuit analysis, and
industry prepared to work toward creative solutions for treating hearing loss. Specifically,
This training program is unique in that it is specifically designed to serve
students with undergraduate degrees in the disparate disciplines of life science, physical science or
engineering, and merge them into a unified cohort focused on auditory neuroscience. Students will be selected
for a 2-year term on the training grant, beginning at the start of their second year. The training curriculum
includes 3 core courses (one each in neuroscience, the auditory periphery, and signal processing), several
recommended courses (e.g., in neurosurgery or neuroscience), a weekly Hearing Science seminar series, and
yearly attendance at extramural hearing-related courses and/or auditory neuroscience conferences. In addition
to administrative support for the program, the Purdue Institute for Integrative Neuroscience will provide
students with additional resources, such as supervised grant writing, hands-on training in animal behavior and
human stem cells, annual neuroscience retreats, and access to in-house competitions for travel grants and
pilot funding for collaborative projects. Further, this program builds on Purdue's extensive history in training
graduate students in collaborative research (particularly in hearing science and technology development), and
preparing these students for successful research careers in academia, industry and the clinic.
multimodal brain imaging methods.

Public health relevance
PROJECT NARRATIVE This Interdisciplinary Training Program in Auditory Neuroscience will provide graduate student training and research experience at the interface of science and engineering, and in both humans and animal models. This training program will prepare students for independent research careers that can advance our understanding of auditory system function using innovative tools and technologies. It is expected that graduates of this training program will develop creative solutions, devices and strategies to assist and prevent hearing loss in human patients.